Intracellular Trafficking of HIV-1 Particles

DESCRIPTION (provided by applicant): Much progress has been made over the past 20 years in understanding the molecular details of HIV biology. Through the research efforts of many laboratories the process of HIV fusion, reverse transcription, integration, the transcriptional and posttranscriptional regulation of HIV gene expression, and viral assembly have been well defined. In contrast, the post-fusion aspects of the HIV lifecycle are less well understood. Clearly, this is a complex area of HIV biology because number of defects in HIV proteins lead to a similar phenotype; reverse transcription is apparently initiated, yet reverse transcription is not completed or the provirus is destabilized. Four years ago my laboratory received support to develop a system that would use the methods of cell biology to study the intracellular trafficking of HIV. The cornerstone of this approach was the incorporation of a fluorescent protein tag into virions utilizing a GFP-Vpr fusion protein. This allowed individual virions and cytoplasmic HIV complexes to be fluorescently identified. Analyzing HIV cytoplasmic complexes revealed new details of the trafficking and biology of the viral genome as translocates to the nucleus. We were even able to obtain electron microscope images of reverse transcription complexes using the fluorescent signal to reveal the cytoplasmic localization of the HIV genome. The studies proposed here seek to build upon our success in developing a cell biological approach to study the biology of HIV between fusion and integration. These studies, based on a cell biological approach, will continue to shed light on this vague aspect of HIV biology. A better understanding of this segment of the viral life cycle may reveal new targets for specific antiviral therapies.